Elucidating novel mechanisms in the pathogenesis of Alport syndrome

PROJECT ABSTRACT
Alport syndrome is the second most common cause of hereditary chronic kidney disease and is
caused by mutations in the type IV collagen genes encoding 3, 4 and 5 chains. X-linked Alport
syndrome (XLAS) accounts for most cases and is caused by mutations of the 5 chain. Therapies
to slow the progression of XLAS are limited and affected males invariably progress to end stage
kidney disease. The disease is known to affect glomeruli: the 3, 4 and 5 (IV) chains are
deposited by podocytes into the glomerular basement membrane, and patients with Alport
syndrome have structural defects in the glomerular basement membrane that causes hematuria
and proteinuria. Despite this, there are major gaps in our understanding of disease pathogenesis.
It is known that other cell types in the kidney produce 3, 4 and 5 chains, but to date, their
function and the role they play in tubule function and disease pathogenesis has been unexplored.
Based on preliminary studies, we hypothesize that 5 from non-glomerular cells is required for
normal cell function and shape, and that the non-glomerular cell abnormalities contribute
substantially to the clinical presentation and pathogenesis of XLAS. We therefore propose to 1)
identify the glomerular and non-glomerular contributions to XLAS pathogenesis and progression,
2) establish the function(s) of 5 in tubular cells, including elucidating signaling pathways that
underlie its role in tubular cells. Together, these studies will generate resources to study type IV
collagen function and will greatly advance knowledge of the pathogenesis of XLAS. We expect
they may also pave the way for future studies that lead to the development of novel therapeutic
strategies.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will advance knowledge of the pathogenesis of Alport syndrome, a hereditary disease that leads to end stage kidney disease in affected individuals. The disease is caused by mutations in the type IV collagen genes encoding 3, 4 and 5 chains, which reside in the glomerular basement membrane. Although their role in glomeruli is well-studied, the role of these collagen chains in kidney tubules is largely unknown. Here we will examine the contribution(s) of tubular cells to the clinical signs, pathogenesis, and progression of this disease.